Gonorrhea and HIV prevention with intravaginal ring drug delivery

ABSTRACT
Sexually transmitted infections, such as HIV and gonorrhea, are a major threat to human health worldwide.
Antibiotic-resistant N. gonorrhoeae have emerged in all parts of the world. Safe and effective vaccines against
gonorrhea and HIV remain elusive. Further, gonorrhea can increase transmission of HIV about 5-fold. Thus,
there is an urgent need to develop novel methods to prevent these STIs.
We have identified a murine monoclonal antibody (mAb) called 2C7 that is directed against a gonococcal
lipooligosaccharide (LOS) epitope that is expressed by ~95% of clinical isolates, has complement-dependent
bactericidal and opsonic activity and attenuates gonococcal infection in the mouse model. A chimeric version
of mAb 2C7 (Ximab 2C7), created in an ongoing collaboration with Genmab, was also efficacious when
administered intravaginally to mice. Introduction of a mutation in human IgG1 Fc that increases IgG
hexamerization and enhances complement activation further enhanced activity of Ximab 2C7. This
collaborative proposal between UMass, Planet Biotechnology, Inc., Oak Crest Institute of Science and
MassBiologics seeks to develop intravaginal rings (IVRs) to deliver fully humanized mAb 2C7 in combination
with tenofovir disoproxil fumarate (intravaginal TDF; proven efficacious in preventing HIV transmission to
women) to prevent gonorrhea and HIV infections.
In the R61 phase (years 1 and 2) of this proposal, we will i) fully humanize mAb 2C7 that contains the
complement-enhancing Fc mutation (Humab 2C7), ii) produce functional Humab 2C7 at a relatively low cost in
tobacco plants, iii) formulate Humab 2C7 along with the tenofovir into IVRs for local vaginal delivery and iv)
prepare for and participate in a pre-IND meeting with the FDA.
In the R33 phase (years 3-5) we will i) perform PK, release and toxicity studies following tenofovir and Humab
2C7 delivery via IVR in an ovine model, ii) test the efficacy of Humab 2C7 against contemporary clinical
multidrug-resistant isolates in novel human factor H (FH) and C4b-binding protein (C4BP) dual transgenic
mice (gonococci bind these complement inhibitors in a human specific manner, thus these mice will provide
the `obstacles' that Humab 2C7 will have to surmount in humans), iii) elucidate the mechanism of action of
Humab 2C7 in vivo using mice that lack complement components (C1q, C3, C5, C5aR) and /or phagocytes
(PMNs, macrophages) and iv) develop a scalable purification process and a set of drug product release
assays appropriate for technology transfer to a contract manufacturing organization.
Successful completion of the proposed work will result in a clinically effective deliverable to prevent HIV and
gonorrhea at the end of the funding period.

Public health relevance
PROJECT NARRATIVE Sexually transmitted infections, such as HIV and gonorrhea, are a major threat to human health worldwide. Antibiotic-resistant N. gonorrhoeae have emerged in all parts of the world. Safe and effective vaccines against gonorrhea and HIV remain elusive. Further, gonorrhea can increase transmission of HIV about 5-fold. Thus, there is an urgent need to develop novel methods to prevent these STIs simultaneously.